GENETICALLY DETERMINED IMMUNODEFICIENCIES--ANALYSES OF DEFECTS AND THERAPIES

The purpose of this study is to define the cellular and molecular bases of the different human primary immunodeficiency disorders so that permanent and/or more effective therapy can be developed. The creation of bone marrow stem cell chimeras has also allowed us a unique opportunity to examine the cellular and molecular bases of human thymic education.